Biostatistics and Data Management

CORE B (BIOSTATISTICS AND DATA MANAGEMENT CORE): PROJECT SUMMARY/ABSTRACT
Core B which has supported the PPG for almost 30 years, consists of a Core Leader (Lu), a Core Physician
leader (Lowsky), a Biostatistician (Tamaresis), a post-doctoral fellow (Bi), and a data manager (TBN), who will
supervise the clinical research assistants (CRAs) and protocol coordinator (in addition to his/her PPG work)
supported by the Stanford University Medical Center and other grants which provide services as needed to
support the PPG aims.
The leader of Core B and the biostatistician have decades of experience in medical research and especially in
clinical trial design and data management work (organization, planning, management, monitoring and analysis)
in collaboration with medical investigators, including many years of collective experience working with the BMT
investigators. The Core B physician leader, Dr. Lowsky, has extensive experience in the development, conduct,
data collection and analysis, study completion and monitoring of single center and multi-center clinical trials. The
Core supports the clinical and preclinical projects and Core C in the proposal by leveraging the depth of expertise
in biostatistics and data science at Stanford University to assist project investigators in all aspects of their studies.
Core B meets weekly to review and plan work, often joined by other key PPG personnel. The Core staff meet
monthly with all clinical research assistants, the program project PI and the other clinical investigators, to resolve
difficulties and problems, for example, in data collection, data flow, definitions, electronic data collection forms
design, and protocol development. Frequent ad hoc meetings between investigators and Core B members are
scheduled, as needed. Each of the 5 new projects in the program project (based on experience and preparation
of plans for the coming years to be supported through this program) will use about the same fraction of Core B
effort (18% each) and the remainder are split between Core C (28%). The Core has 5 specific aims: 1) provide
biostatistics consultation and support to the PPG project investigators in animal studies and clinical trials, 2)
develop biostatistics and bioinformatics methods and tools to correlate outcome, toxicity, and efficacy,
coordinating support between projects and Core C, 3) maintain all standard procedures and use the best data
science practice for assuring quality of the data collected, reproducible analysis, and production of management
reports, 4) aid in assembling, summarizing, and analyzing data for regulatory, operational, and scientific
reporting, and 5) coordinate and consult with the hospital-supported maintainers of the BMT database. Core B
is committed to active and continued participation in the PPG to help ensure that project Aims are fulfilled in the
most scientifically meaningful manner.

Public health relevance
CORE B (BIOSTATISTICS AND DATA MANAGEMENT CORE): PROJECT NARRATIVE Core B supports the clinical and pre-clinical projects and Core C in the proposal by leveraging the depth of expertise in analytics at Stanford University to assist project investigators in all aspects of statistical needs for their studies. Core B has been successfully carrying out this mission with the same study team for nearly 30 years and has helped the PPG investigators shape the field of Hematopoietic Cell Transplantation as well as the current applications.